This proposed R13 application will focus on Endocrinology, Diabetes and Metabolism, HIV/AIDS, Gastroenterology, Cardiology, Pulmonology, Nephrology, and Oncology subspecialty topics.

This proposed R13 application will focus on Endocrinology, Diabetes and Metabolism, HIV/AIDS,
Gastroenterology, Cardiology, Pulmonology, Nephrology, and Oncology subspecialty topics. It is titled
NMA 2020 Equipping the Next Generation of Internal Medicine Physicians for Success. The
program will be utilized to enhance the development and training of young investigators who have an
interest in academic medicine and research, with a demonstrated desire to address health disparities.
Due to decreasing numbers in women securing tenured track positions in academia, this year we will
make a concerted effort to focus on providing valuable information to help trainees facilitate the
successful transition from trainee to faculty member. Award recipients will present their posters during the
NMA General Poster Presentation session. This enables our early career investigators to be exposed to
and interact with a broader audience of physicians beyond the internal medicine specialty. Additionally,
the highest scored abstracts will be invited to present their research in the form of a brief oral presentation
within the appropriate subspecialty section during the IM sessions. NMA Internal Medicine (IM)
leaders/senior faculty will be available to network with and participate in small group discussions with
early career investigators.
There are seven objectives to this conference session: (1) Provide a forum for cross-disciplinary
exchange of ideas to further explore issues of health disparities and health equity; (2) Foster opportunities
for early stage minority faculty and trainees to network and learn about current research in the internal
medicine specialty; (3) Promote opportunities for all early stage faculty and trainees to present their
research findings during the general NMA poster session and our general IM Session meeting; and
integrate the top recipients of the abstract submissions as oral abstract presentations within the
appropriate Internal Medicine specialty presentations; (4) Promote opportunities for trainees to buttress
this academic experience by allowing them to attend an array of NMA general Scientific Section symposia
during the entire NMA Convention period; (5) Promote opportunities for early stage faculty and trainee
investigators to interact with more senior investigators working in the internal medicine specialties to
enable them the opportunity to establish professional relationships that will provide early career guidance
and for those interested “groom” them for future leadership in the NMA; (6) Provide effective tools to
address unique challenges faced by early career professional women in academia; (7) Introduce scholars
to the different academic tracts and provide guidance to achieving tenure.

Public health relevance
This program is designed to foster the research pipeline of underrepresented trainees and early career investigators examining the barriers and root causes behind health disparities through mentorship and through the opportunity to participate in a national scientific conference focused on these issues. The results of increased health disparities/health determinants research -- particularly among underrepresented communities -- may ultimately lead to improved population and community health, which is safer, more accessible, affordable, and equitable.